DROSOPHILA GENOMICS RESOURCE CENTER

Project Summary:
The Drosophila Genomics Resource Center (DGRC) supports the international community of scientists
utilizing Drosophila melanogaster for biomedical research. The mission of the DGRC is to 1) provide
broad access to genomics resources by acquiring, authenticating, archiving, curating, and distributing
genomics resources including clones, vectors, and cell lines; 2) facilitate effective use of these genomics
resources by providing guidance and support; and 3) improve the genomics resources and protocols
available for Drosophila research. By preserving vital research materials and distributing them efficiently,
the DGRC assures economical access to important research reagents, and enhances scientific rigor and
reproducibility. The first aim of this proposal is to continue to strengthen the successful DGRC programs
by: A) Continue to acquire, archive, curate, and distribute Drosophila resources including clones,
vectors, and cell lines for supporting fundamental research of biological processes and modeling of
aspects of human disease. B) Pilot a program with Indiana University Clinical and Translational
Science Institute (CTSI) to promote Drosophila genomics reagents for use in non-Drosophila labs;
C) Manage the cost recovery program and resource center to maximize the long-term viability of the
DGRC and the benefits to its users and the NIH. The second aim is to improve and update our
curation process, data management systems and web interface, and incorporate FAIR and TRUST
guiding principles into our reagents, metadata and linking data to other repositories. The goal is to
maximize the long-term viability of the DGRC and its benefits to users and the NIH. The third aim is to
increase the utility of Drosophila as a model system by generating new resources and protocols through
four projects: A) Increase the authentication, and reproducibility and quality control of DGRC reagents; B)
Generate gut derived cell lines and pilot and expand to generate a neuroblast derived cell line; C)
Continue to expand the catalog of recombination mediated cassette exchange compatible stable attP
Drosophila cell lines; D) Collaborate to develop metabolic sensors and standards for aerobic glycolysis
and other biosynthetic pathways.

Public health relevance
Project Narrative: The proposed research is relevant to public health and the mission of the NIH because Drosophila has been and continues to be a leading model organism to study fundamental biological processes and molecular and cellular mechanisms of human disease. The Drosophila Genomics Resource Center is a central repository and distribution center for genomic resources essential for research in Drosophila.